Pathogenic Tau Promotes Brain Vascular Dysfunction in Alzheimer's Disease

The coupling of neural activity and increased blood flow (neurovascular coupling) is vital to brain function.
Failure of this coupling occurs early in Alzheimer’s disease (AD) and ‘pure’ tauopathies and induces chronic
brain injury, contributing to neurodegeneration. Among other mediators, neurovascular coupling is regulated by
nitric oxide (NO) bioavailability. NO formed by the neuronal form of nitric oxide synthase (nNOS) is central to
neurovascular coupling, and its production by nNOS-­expressing interneurons depends on microtubule-­
dependent transport of nNOS to dendrites. Tau protein, causally implicated in AD, stabilizes microtubules. Under
pathologic conditions, hyperphosphorylated tau detaches from microtubules, destabilizing the microtubule
cytoskeleton. Soluble hyperphosphorylated tau aggregates transfer trans-­neuronally, promoting native tau
phosphorylation and microtubule destabilization in target cells. Among the neuron types targeted by tau
pathology in AD are vasculature-­associated nNOS-­expressing neurons. The functional impact of pathogenic
tau on nNOS neurons, and its contribution to brain vascular dysfunction in AD, have not been explored and are
not understood. The objective of this proposal is to define mechanisms of pathogenic tau-­induced brain
vascular dysfunction and determine whether removing pathogenic tau with immunotherapy is a potential
treatment for AD. We hypothesize that soluble tau aggregates critically contribute to brain vascular dysfunction
in AD by blocking nNOS activation, and that removal of soluble tau aggregates with immunotherapy will
prevent and potentially treat brain vascular dysfunction by restoring nNOS activity. Our studies show that
aggregation-­prone human tau causes neurovascular coupling deficits driven by reduced nNOS activation in
models of AD tauopathy;; and that transmission of soluble aggregated tau into neurons blocks nNOS activation,
suggesting that pathogenic tau drives brain dysfunction by impairing nNOS. We will test our central hypothesis
by pursuing two Specific Aims. In Aim 1, we will define the mechanisms by which soluble tau aggregates
impede nNOS activation using in vitro approaches, and identify molecular alterations triggered by tau
aggregates in vivo in microvasculature-­associated neurons during disease progression in a mouse model of
AD tauopathy. In Aim 2, we will establish the therapeutic potential of soluble aggregated tau removal in AD
cerebrovascular dysfunction, using antibody-­based removal of soluble tau aggregates early in AD progression
and after disease onset, and determine, in human AD brains, how accumulation of tau aggregates and
molecular alterations identified in Aim 1 correlate with AD histopathology and progression. The role of tau in
AD cerebrovascular dysfunction is unexplored. As a result of the work proposed, we expect to (a) identify
soluble tau aggregate-­induced molecular alterations that diminish nNOS activity, (b) define the impact of nNOS
impairment by soluble aggregated tau in cerebrovascular deficits of AD, and (c) evaluate whether tau
immunotherapy may have promise for AD. These results are expected to markedly advance our understanding
of how pathogenic tau, and cellular events it triggers, can be targeted for therapeutic purposes. In addition, this
study will contribute novel insights into the role of tau in cerebrovascular dysfunction of AD and other
tauopathies. Equally important, the results of this study will have a positive impact because the identification of
soluble aggregated tau as a driver of AD cerebrovascular dysfunction will reveal novel targets for therapies and
propel forward new research in cerebrovascular biology and neurodegeneration.

Public health relevance
Energy substrates need to be delivered to active areas of the brain ‘on demand’ through its blood supply. Failure of coupling between neural activity and increased blood flow (neurovascular coupling, NVC), vital to brain function, occurs early in Alzheimer’s disease (AD) and ‘pure’ tauopathies. Our studies will define how transmission of pathogenic tau protein, causally implicated in AD, into specialized neurons associated with brain vasculature drives NVC failure in models of AD tauopathy by blocking the activation of the neuronal form of nitric oxide synthase, critical to the NVC response. Because the role of tau in AD brain vascular dysfunction is unexplored, our studies will reveal novel mediators of cerebrovascular dysfunction in AD, identify novel targets for therapies, and propel forward new research in cerebrovascular biology and neurodegeneration.